Targeting NAD Metabolism to Improve Glucose Homeostasis in Obesity and Aging

Targeting NAD Metabolism to Improve Glucose Homeostasis in Obesity and Aging
We are testing the hypothesis that nicotinamide adenine dinucleotide (NAD+) metabolism can be targeted to
improve physiology in aged and obese individuals. NAD+ is a ubiquitous molecule that is required as a redox
cofactor or substrate for hundreds of enzymes within the cell. It can be derived from dietary tryptophan, niacin,
nicotinamide, or administered synthetic intermediates. Prolonged deficiency of all of these precursors leads
to pellagra (characterized by dermatitis, diarrhea, and dementia) and eventually death. In recent years, it has
become appreciated that NAD+ concentration falls in many tissues with age or obesity, and that the
pathogenesis of many diseases includes a component of NAD+ depletion within the target tissue. Multiple
groups, including ours, have established that high doses of precursors have therapeutic effects in rodent
models of disease. However, much remains to be learned about NAD+ metabolism, even as nutraceutical
formulations containing precursors are being marketed to the general public. A substantial weakness of the
current literature is that most of the published studies involve systemic treatment and measurement of only
distal phenotypes, such as rudimentary blood biomarkers, general health, or disease outcomes. Because of
this, the molecular mechanisms and sites of action for pre-clinical and clinical studies involving NAD+ often
remain obscure, even for positive outcomes, while negative outcomes remain difficult to interpret. The major
focus of our work during the prior award cycles has been to develop mass-spectrometry and genetics-based
models to understand the metabolism of NAD+ precursors, their effects on cellular metabolism, and critical
tissues and sites of action. Here we propose to extend these studies by: 1) Characterizing the effects of
changes in NAD+ availability on subcellular distribution of the co-factor and on flux through NAD-dependent
steps in glucose metabolism, 2) Mapping the distribution and metabolism of emerging alternative NAD+
precursors that might have more favorable uptake or stability profiles after oral delivery, and 3) Taking
advantage of our recent discovery of the mammalian mitochondrial NAD+ carrier to study the consequences
of selectively manipulating that NAD+ pool in vivo in liver and skeletal muscle. Together, the proposed studies
will substantially advance our understanding of both the basic biology of NAD+ metabolism and how it might
ultimately be targeted to improve health and alleviate conditions associated with aging and obesity.

Public health relevance
Relevance Supplementing vitamin B3 derivatives to increase nicotinamide adenine dinucleotide (NAD+) has recently shown promise in preclinical studies for multiple indications. However, this promise is based on a dosing strategy that may not be feasible in humans and much remains to be learned about the pharmacokinetics, mechanisms of action, and therapeutic potential of these molecules at doses that can be tolerated. This grant uses genetics and state of the art mass spectrometric techniques to test the sensitivity of biochemical pathways to fluctuations in NAD+ availability, determine where in the cell NAD+ is required for beneficial effects, and to identify alternative forms of vitamin B3 that might be more therapeutically effective.